GLUCOSE METABOLISM AND INSULIN ACTION IN HUMAN SKELETAL MUSCLE CULTURE

Evaluate insulin action and glucose metabolism in human skeletal muscle culture system and further to study the effect of various metabolic perturbation studies on the pathways of insulin action in human skeletal muscle culture.